SEQUELAE OF TRANSFUSION AND DONATION

This project will study the immunologic sequelae of transfusion and plasma and platelet donation by apheresis. This study will concentrate on newborn infants because they have demonstrated a greater incidence of transfusion-associated AIDS. Cell markers, lymphocyte proliferation assays, opsonic activity, natural killer cells and activity and response to antigen stimulation will be evaluated up to 3 years after transfusion.